Evaluating the feasibility of an innovative point-of-care screening tool for detection of infant motor delay within the newborn period

The onset of many chronic neurodevelopmental conditions, such as cerebral palsy, neuromuscular
conditions, and other neurogenetic disorders occur within the perinatal phase of life. Detection of these
conditions, during infancy, when brain plasticity is at its highest, has the potential to dramatically improve
long term outcomes. In the United States (U.S.) the age of diagnosis of conditions such as cerebral palsy
is around 2 years of age for children who had known perinatal risk factors. As many as half of the
children with a disability, however, are from an uncomplicated pregnancy and the diagnosis typically
occurs even later in life. Alarmingly, a diagnosis for a child from an underserved community can be as
late as 5 years of age. The traditional paradigm for diagnosis of these conditions, uses a ‘wait-and-see’
approach until the child eventually misses motor milestones, thus the infant has missed critical months of
possible early intervention. For infants with perinatal risk factors, a diagnosis is sometime achieved
through the use of costly technologies, such as magnetic resonance imaging; or specialized evaluation
techniques, such as the General Movements Assessment (GMA). However, these tests are typically only
available in tertiary care centers. Thus, a point of care newborn screening system could transform the
diagnostic process, allowing every child the opportunity for early detection of aberrant movement
patterns within the newborn period. Our innovative system, BabySure uses an artificial intelligence
model to evaluate infant movement characteristics from a simple, non-invasive video recording. Our pilot
data has shown that BabySure can evaluate and categorize spontaneous movements as healthy or
aberrant in infants before the age of 6 months. To ensure every baby has the opportunity to receive an
early, accurate diagnosis, we will pilot a newborn screening program in a community newborn nursery.
BabySure uses automated skeletal tracking to extract positional coordinates of 33 skeletal landmarks
from each video frame of the infant’s spontaneous movements (including points on the extremities, head,
face, and trunk). An essential part of our project is to continue our efforts to validate our system on a
variety of skin tones as historically, computer vision has not been sufficiently accurate on darker skin. To
train our model to identify aberrant movement we will use the gold-standard GMA to classify infants in
aberrant or healthy movement training groups. Our analysis plan will prototype three artificial intelligence
base models to ensemble a single classifier (each with two heads: regression and classification)
including fine tuning convolutional neural networks pre-trained for image processing and custom-training
models. The final model will output a motor function score that will classify the infant movement as typical
or aberrant. In addition, we will evaluate the intra- and inter-day variability of results to inform future
recommendations for optimal timing or sequence of movement screening across the newborn period.

Public health relevance
We plan to establish the feasibility of using a video-based artificial intelligence model as a point of care, newborn screening tool to universally identify infants with aberrant movement patterns associated with cerebral palsy or other neuromuscular/neurogenetic conditions with a motor component. The identification of infants with aberrant movement within the newborn period will enable early referrals, diagnosis and potentially access to treatment options within a critical early window of brain plasticity. We will evaluate the intra- and inter-day variability of results to inform the optimal timing and/or sequence of newborn, point of care screening(s) to ensure accurate classification and reporting. Knowledge gained through this proposal will position us to apply for larger, multi- year funding that will not only help continue to grow the data corpus but will also allow for longitudinal data mining to provide our model with precise diagnoses from videos captured within the newborn period to further enhance accuracy, sensitivity, and specificity of the model’s classifications of typical or aberrant movement patterns.